Multimodal AI Fusion Model for Early Detection for Pancreatic Cancer

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC), accounting for 90% of all pancreatic cancers, is among the
deadliest, due largely to late-stage diagnosis and the aggressive nature of the disease. The critical challenge
lies in early detection, which is currently not viable for the general population due to low annual incidence and a
significant risk of false positives even with highly specific tests. While current risk assessment tools rely on static
factors such as age, obesity, and diabetes, recent studies suggest the potential for imaging biomarkers derived
from pre-cancerous computed tomography (CT) scans to predict PDAC. Our project aims to develop a
comprehensive and scalable risk prediction model that fuses imaging and non-imaging data to enable early
detection of PDAC in asymptomatic individuals. The model, termed "PRECISE" (PancREas Cancer multImodal
riSk prEdiction), will employ novel algorithmic adversarial debiasing techniques to ensure fairness, meaning it
should perform accurately across different demographic and socioeconomic subgroups. In Aim 1, we will develop
deep learning models that segment imaging biomarkers from abdominal CTs, applying adversarial debiasing to
ensure fair representation across diverse patient factors and image acquisition techniques. Validation will be
done using data from Mayo Clinic, Cornell University, and UCSF. Aim 2 involves the creation of the PRECISE
fusion model. It will combine imaging biomarkers from CTs with clinical data from electronic medical records
(EMRs) to predict the risk of PDAC. We will employ a graph neural network model to capture the semantic
relations between multimodal data. The model's prognostic performance will be compared with baseline models.
In Aim 3, we plan to deploy and evaluate the PRECISE model prospectively across disparate geographical sites.
The model's performance will be assessed by comparing its predictions with patient outcomes collected at
regular intervals. This proposal's overall goal is to create a fair and effective PDAC risk prediction tool, PRECISE,
that leverages both imaging and non-imaging data to calculate unbiased risk estimates. If successful, our
scalable automated risk stratification could potentially transform PDAC early detection, enabling opportunistic
screening for patients undergoing routine abdominopelvic CT scans for non-pancreatic cancer indications. This
could significantly improve PDAC survival rates by enabling earlier intervention and treatment.

Public health relevance
PROJECT NARRATIVE Our project aims to transform early detection and screening methods for Pancreatic Ductal Adenocarcinoma (PDAC) by developing a 'fair' fusion model, “PRECISE” (PancREas Cancer multImodal riSk prEdiction), which integrates imaging and non-imaging biomarkers from multisite cohorts. The model leverages deep learning and adversarial debiasing techniques to incorporate diverse clinical data, enabling more effective risk predictions, especially for minority subgroups. Through a scalable automated risk stratification, we aspire to provide opportunistic screening to patients undergoing routine abdominopelvic CT exams, aiming for an early and accurate prediction of future PDAC risk.